A role for maternal helminth treatment to alter central inflammation and to reduce lifelong offspring inflammation

PROJECT SUMMARY
Neuroinflammation is correlated with a broad spectrum of disorders, including cognitive and mental
health disorders. Treating and reducing neuroinflammation remains a medical challenge. The
purpose of this research is to determine the effects of maternal helminth colonization on her neonatal
and adult offspring, specifically focused on the effects on microglia function and inflammation across
the lifespan as well as hippocampal-dependent behavior in adulthood. As previous work has shown,
neonatal infection alters neuroinflammation via changes in microglial function and has an enduring,
negative effect on adult learning and memory. Current work in patient populations suffering from non-
communicable inflammatory disorders, such as multiple sclerosis, shows that treatment with
commensalist parasites may be a new form of intervention beyond pharmaceutical treatments.
Commensalist organisms emit anti-inflammatory signals in order to survive, and these signals may
have potential benefits by reducing inflammation within their hosts. Previous work has shown that
maternal helminth colonization attenuates neuroinflammation in the offspring following a neonatal
infection with Escherichia coli. The same work showed that the combination of maternal and weanling
offspring helminth colonization rescues learning deficits on a hippocampal-dependent contextual fear
conditioning task. Further research is needed to understand the effects on the offspring of maternal
helminth colonization alone as well as to define the duration and time course of the effects of
maternal helminth colonization in our neonatal infection model. This proposal will test the hypothesis
that maternal helminth colonization alone is sufficient to protect offspring from the lifelong effects of
neonatal infection by reducing inflammation within the hippocampus throughout the lifespan. It will
also characterize the effects of maternal helminth colonization on the offspring to explore possible
mechanisms, including mRNA-sequencing of isolated cell populations (microglia, astrocytes and
neurons) from the central nervous system. Importantly, this project proposes to engage and train
approximately 8 undergraduates working in the lab each year with rodents on behavioral task
analysis as well as cellular and molecular analysis techniques, such as immunohistochemistry and
real-time quantitative PCR as well as bioinformatics projects with NextGen RNAsequencing. These
studies will elucidate potential mechanisms for the effects of maternal helminths that can be further
explored as interventions for populations susceptible to immune-mediated inflammatory diseases.

Public health relevance
PROJECT NARRATIVE This proposal will characterize the effects of an anti-inflammatory treatment in mothers that will reduce inflammation in their babies. It will identify target pathways for early-life inflammation that can be the focus of prenatal interventions to reduce the burden of inflammation and the lifelong effects of early-life adverse events.